Virology Core

ABSTRACT – VIROLOGY CORE
The Virology Core will continue to support the ongoing research of the Program by providing customized
virological techniques and services performed at a centralized location using standard operating procedures to
ensure maximal data consistency. The services provided include virus mutant design and construction for
Projects 2 and 3, as well as viral stock production and quality control across all projects. Furthermore, the
core will be tasked with receiving all bodily fluids and tissues collected from rhesus macaques in virus
challenge experiments over the course of the Program to centrally store, process, and analyze samples. The
raw data will be stored centrally through the Admin Core to all project PIs for review and interpretation. The
Virology Core team is composed of a group of scientists with years of experience in diverse, non-overlapping
areas in basic and translational virology. We can offer guidance and support on a wide range of techniques,
including genomic engineering and virus production, tissue handling and processing, next generation
sequencing, and data analysis either for quality control purposes or to answer complex research questions
involving in vivo virus population analysis and virus evolution. Our pre-existing collaboration will allow us to rely
on exstablished, standard operating procedures (SOPs) and pipelines for rapid and reliable sample processing
and data generation. All members of the Virology Core are acquainted and have successfully worked together
for years in a highly collaborative environment to support intricate multicenter research studies involving NHPs.
Hence, the scientific members of the core are in constant communication, and issues and obstacles that might
arise over the course of the Program will be discussed, analyzed, and managed collaboratively in a timely
manner in close cooperation with the scientific leadership. If needed, the overall goals and responsibilities of
the Virology Core can be adjusted by the project administration. Should new techniques or procedures be
required for any project, the Virology Core team member with the most relevant expertise in the desired field of
research will be tasked with establishing these procedures for general use.